DIURNAL AND SECRETION BY THE PARATHYROID GLANDS IN CHRONIC RENAL INSUFFICIENCY

Secondary hyperparathyroidism (HPT) is almost invariable consequence of chronic renal insufficiency. Despite numerous recent advances, the pathophysiology of parathyroid hormone(PTH) secretion in chronic renal failure has yet to be fully characterized; this is due, in part, to the fact the reliable measurements of intact PTH in sujects with advanced renal failure have been available for only a few years.